Continuation of the NuMoM2b Heart Health Study

PROJECT SUMMARY/ABSTRACT
Adverse pregnancy outcomes and complications such as preterm birth, preeclampsia,
intrauterine growth restriction, and gestational diabetes present significant risks to pregnant people.
The nuMoM2b Heart Health Study (nuMoM2b-HHS2) determines the cardiovascular and
cerebrovascular health impact of such adverse pregnancy outcomes through following nearly 7,000
people from first pregnancy through 8-16 years post-partum. The nuMoM2b-HHS2 work has helped
increase understanding of high blood pressure indicators, impact of exercise, sleep disorders,
neighborhood characteristics, stress and depression, SES factors and biological influences on
future health and disease. We propose to support 2-3 early career investigator scholars with
meritorious proposals for additional analyses of the data. Using a similar approach in the past,
early-career investigator scholars, through a competitive and peer-reviewed process, had projects
selected for internal support. This led to two obstetricians, one cardiologist, and one neurologist
being newly integrated as active participants in the nuMoM2b-HHS2 network, as well as papers that
were published in peer-reviewed journals. These future 2-3 awards will require administrative and
technical support for the scholar, as well as the analysis of data generated, which will be completed
by the nuMoM2b-HHS2 team at RTI. For the nuMoM2b-HHS2 network, this proposal aligns well
with the Trans-NIH Strategic Plan for Women’s Health Research, particularly Goal 4: Promote
Training and Careers to develop a well-trained, diverse, and robust workforce to advance science
for the health of women. The nuMoM2b-HHS2 team would value the opportunity to support
additional scholars this year, continuing to maintain a strong focus on diversity. RTI will provide an
ideal setting for support of young investigators from various disciplines to engage them in this
unique area of science and promote strong collaborations that will propel the science forward.

Public health relevance
PROJECT NARRATIVE The nuMoM2b Heart Health Study (nuMoM2b-HHS2) follows approximately 7000 people from first pregnancy through 8-16 years postpartum to determine the impact of adverse pregnancy outcomes on future cardiovascular and cerebrovascular health and disease. In recent years, investigator scholars have obtained support, through a competitive and peer-reviewed process, for various studies that have led to both papers that were published in peer-reviewed journals and the investigators becoming fully integrated and actively participating in the nuMoM2b-HHS2 network. To support and align with the Trans-NIH Strategic Plan for Women’s Health Research, particularly Goal 4: Promote Training and Careers to develop a well-trained, diverse, and robust workforce to advance science for the health of women, this proposal will support 2-3 additional scholar awards that will provide analysis support and monetary awards to the award recipients.